Center of Excellence for Encephalitic Alphavirus Therapeutics

Program Abstract- Overall
The proposed Center of Excellence for Encephalitic Alphavirus Therapeutics program proposes to advance
the development of potent small molecule leads targeting Venezuelan equine encephalitis virus (VEEV), Eastern
equine encephalitis virus (EEEV) and Western equine encephalitis virus (WEEV) or V/E/WEEV herein. The
collaborations among the scientists at University of Louisville (UofL; Chung), University of Wisconsin-Madison
(UW; Golden, Elder), University of Tennessee Health Science Center (UTHSC; Jonsson, Meibohm, Fitzpatrick,
Tigabu) and University of Texas Medical Branch at Galveston (UTMB; Rossi, Weaver) provides multidisciplinary
expertise in virology with relevant expertise in ABSL-3/select agents, small and large animal models, medicinal
chemistry, pharmacokinetics, and assessment of antiviral compounds in vitro with mechanism of action
capabilities. Moreover, the network has an experienced team led by UTHSC (Bares) to organize the commercial
plan for development of the broad-spectrum antiviral (Encephlavir) for treatment against V/E/WEEV. The broad,
long-range objectives of the Center are to; (1) Optimize the lead quinazolinone series to identify those with
favorable profiles for nonGLP studies with WEEV and EEEV that have broad-spectrum activity for V/E/WEEV;
(2) Define scale-up synthesis of the lead drug substance suitable for later cGMP manufacturing; (3) Conduct
nonclinical virology studies that will aid in the evaluation of the safety and efficacy, the mechanism of action,
target specificity and drug resistance monitoring plan. The proposed multidisciplinary efforts will advance this
lead series through IND-enabling studies. Following the disciplined product development plan, the ultimate goal
of the Center is to move toward a commercially available prophylactic and/or therapeutic treatment for VEEV,
EEEV, and WEEV as the primary indication.

Public health relevance
Project Narrative The goal of the proposed Center of Excellence for Encephalitic Alphavirus Therapeutics program is to advance the lead optimization and development of potent, small molecule, replication inhibitors as antiviral drug candidates targeting Venezuelan equine encephalitis virus (VEEV), Eastern equine encephalitis virus (EEEV) and Western equine encephalitis virus (WEEV). The encephalitic alphaviruses are important epidemic and biothreat agents which have no effective therapeutics to treat the diseases that they cause in human populations. Naturally transmitted by mosquitos to humans, these encephalitic alphaviruses cause severe disease and life-threatening encephalitis in humans with case fatality rates up to 75% depending on the virus.